FUSION GLYCOPROTEIN OF RESPIRATORY SYNCYTIAL VIRUS

We have used 18 neutralizing monoclonal antibodies (MAbs) specific for the respiratory syncytial virus (RSV) fusion (F) glycoprotein to construct operational, topologic, and functional epitope maps of this F glycoprotein. The MAbs define 16 neutralization epitopes which are organized into three non-overlapping antigenic sites (A,B,and C) and one bridge site (AB). Neutralization and fusion-inhibition tests of the MAbs indicated that antigenic sites A,AB,and C correspond to domains of the F protein that affect syncytium-formation, whereas antigenic site B is more distant from the fusion site. This interpretation is supported by two additional observations. First, MAb-resistant variants selected with site B MAbs produce normal plaques, whereas those selected with MAbs binding epitopes in sites A and AB produce pinpoint plaques. Second, epitopes in antigenic sites A,AB,and C (which correspond to domains close to the fusion site) were less variable among RSV clinical isolates than were epitopes in antigenic site B. Sequence analysis of the F genes of antibody-resistant mutants is currently in progress. This information will allow us to identify amino acid residues which are involved in binding neutralizing antibodies and which directly affect syncytium-formation.